Development of an intra-body wireless sensor link for COSMIIC NNP

Abstract Summary
Development of an Intra-body wireless sensor link for COSMIIC NNP
This supplement will develop new capabilities for the COSMIIC System. Two modules under
current development are the “WING” and Sensor Withdrawn from A Remote Module
(SWARM). These will allow for real-time feedback of physiologic data to facilitate control for
closed-loop nerve stimulation algorithms. The WING module is intended to connect to wireless
devices and sensors outside the body, and the SWARM is designed for connection to tethered
sensors like inertial measurement units (IMUs) inside the body. Neither module, however,
supports data communication from untethered sensors within the body. With this supplement,
we propose to develop an intra-body wireless link that interfaces with the SWARM to enable
untethered, remote sensors to connect to the COSMIIC system. This will allow the COSMIIC
system to receive physiological feedback from sensors which cannot be safely accessed using
wires, or from sensors that only reside in the body for limited periods.

Public health relevance
Project Narrative Development of an Intra-body wireless sensor link for COSMIIC NNP The aim of this supplement is to create a COSMIIC System module that can wireless connect with wireless sensors indwelling in the body, such as a bladder pressure sensor.